Social and behavioral determinants of health and Alzheimer’s Disease: Cohort study of the US military veteran population

Social and behavioral determinants of health and Alzheimer’s Disease
Alzheimer’s Disease (AD) affects an estimated 5.8 million US adults. Veterans are particularly susceptible to
AD due to demographic, clinical, and economic factors. Social determinants of health are the conditions in
which people are born, live, work, and age. Adverse social determinants of health include job loss and financial
and food insecurity. Together with behavioral health factors (e.g., smoking and substance use) and mental
health, adverse social and behavioral determinants of health (SBDH) contribute to adverse health outcomes.
Associations between SBDH and AD have been noted, but most studies used structured electronic health
record (EHR) or survey data. SBDH are not routinely added to structured EHR. Natural language processing
(NLP) approaches can be developed to automatically extract SBDH and their attributes. The specific aims are:
Aim 1: Establish NLP-enriched case definitions of adverse SBDH and AD-related information (e.g., signs and
symptoms of cognitive decline), and examine their incidences by first chart-reviewing ~5,000 EHR notes (e.g.,
primary care, neurology, psychiatric, and social work notes) using the MGB dataset and then develop and
evaluate sophisticated NLP systems to automatically capture SBDH and AD-related information. We will evaluate
the generalizability of the NLP models on the VA and non-VA MGB datasets. We will also conduct domain-
adaptation and will evaluate large language models for zero or few-shot learning.
Aim 2: Using NLP enriched SBDH as independent variables from a nested case-control design, we will
analyze the associations between adverse SBDH and incident AD among both VA and non-VA populations
and subpopulations. We will also evaluate how the associations vary by age, sex, race/ethnicity. We will
compare results using NLP-enriched SBDH vs. using structured data (only) SBDH. Hypothesis 1: Patients with
adverse SBDH have substantially higher incident AD risk, after adjusting for potential covariables (e.g., patient-
specific demographic and clinical factors). Hypothesis 2: The effects of adverse SBDH on AD risk vary by age,
sex and race/ethnicity, after adjusting for covariables (e.g., patient-specific clinical factors). Hypothesis 3: The
effects of adverse SBDH on incident AD are likely dose- and duration-dependent, with more and longer
adverse SBDH leading to higher AD risk.
Aim 3: Early AD diagnosis may prevent or delay AD development through intervention efforts on SBDH.35
Cognitive decline occurs 5-8 years prior to AD diagnosis.36 We will study whether inclusion of NLP-enriched
adverse SBDH and AD-related information helps early diagnosis of AD. We will use three types of predictive
models: statistical regression, traditional machine learning, and innovative deep learning models. We will
evaluate the generalizability of the predictive models on both the VA and non-VA MGB datasets. We will also
evaluate and develop efficient domain-adaptation approaches.

Public health relevance
Social and behavioral determinants of health and Alzheimer’s Disease Social determinants of health are the conditions in which people are born, live, work, and age. Adverse social determinants of health include job loss and financial and food insecurity. Together with behavioral health factors (e.g., smoking and substance use) and mental health, adverse social and behavioral determinants of health (SBDH) contribute to AD. Natural language processing approaches can be developed to automatically extract SBDH and their attributes to study the associations between SBDH and AD.